Administrative Core

The administrative home for the management of this Center and the various participating cores is the Gene Therapy Program of the Division of Transfusion Medicine of the Department of Pathology and Lab Animal Medicine which is headed by the PI of this grant, Dr. James M. Wilson. The Dean of the Medical School provides financial support to this program. Dr. Maria Limberis the Gene Therapy Department is the Co-Pi of the grant and Ms. Kelly D. Reynolds, who is the Director of Finance and Operations for the Gene Therapy Program, provides all administrative support for the activities of the Center. A number of administrative vehicles are in place to assure the Center and its participating cores meet the objectives of the program. Independent weekly core management meetings are held to review activities of the cores including the following: Vector and Immunology Core Management meeting, Cell Morphology Management meeting, and Animal Models Core Management meeting. Internal and External Oversight Committees are in place to review the activities of the Center. The Gene Therapy Program coordinates a Gene Therapy Seminar Series which is partially sponsored by this Center. Finally, the Administrative Core oversees all aspects of the Pilot and Feasibility Program.

Public health relevance
This Core will provide all administrative support for the implementation of the program. Both an External Scientific Advisory Committee and an Ethics Advisory Board will be convened.